Understanding the role of mitochondrial dysfunction in cardiac arrhythmias using a novel 3D panoramic optical mapping system

ABSTRACT
Cardiac arrhythmias are a major cause of morbidity and mortality, and are increasingly prevalent due to an aging
population with diabetes, heart failure and hypertension. Atrial fibrillation (AF) and ventricular fibrillation (VF), are
chaotic arrhythmias, whereas, atrial tachycardia (AT), atrial flutter (AFL) and ventricular tachycardia (VT) are
more organized, focal or macro-reentrant arrhythmias. Our grasp of the specific mechanisms that allow for the
cardiac substrate to harbor organized and/or chaotic rhythms is incomplete. Causative factors of arrhythmias
include fibrosis, increased late Na+ current and increased reactive oxidative stress (ROS) causing augmented
mitophagy, which is a process of eliminating defective mitochondria to maintain the overall health of the
mitochondrial pool. Our methodological breakthrough is to use 3D panoramic anatomical and optical mapping,
in conjunction with mitophagy detection to characterize the interplay amongst electrical activation, substrate
heterogeneity due to fibrosis and mitophagy, and action potential duration (APD) heterogeneity. Our proposed
concept is that larger or greater number of areas of fibrosis, APD heterogeneity and/or mitophagy will allow for
more chaotic atrial or ventricular arrhythmias. By individually disrupting these pathways and defining the
consequences on arrhythmogenesis, we will determine how these three processes are co-regulated or
functionally inter-dependent. We crossed mice with a reporter Keima protein which detects mitophagy, together
with two lines of transgenic mice with spontaneous and sustained AF, AFL, AT, VT and VF due to mutations in
the human cardiac NaV1.5 channel gene SCN5A. This project presents an integrated experimental approach
using (1) multi-modality imaging of whole hearts of murine models of Na+ overload with AF, AFL, AT, VT and VF
or myocardial infarction induced VT/VF to understand the mechanisms of organized and chaotic atrial and
ventricular arrhythmogenesis, (2) AAV delivery of mitochondrial catalase to reverse increased mitophagy after
myocardial infarction and (3) optogenetics via AAV delivery of channelrhodopsin-2 into whole murine hearts and
use of focused light stimulation to trigger, prevent and terminate atrial and ventricular arrhythmias. The proposed
experiments are highly significant and innovative in that co-registered 3D panoramic imaging will allow us to
dissect the mechanisms that drive organized and chaotic cardiac arrhythmias, which may lead to new and
effective treatment strategies of cardiac arrhythmias.

Public health relevance
PROJECT NARRATIVE Atrial and ventricular cardiac arrhythmias are a major cause of morbidity and mortality. Reactive oxidative stress, mitophagy, fibrosis and electrophysiological abnormalities are known to contribute to cardiac arrhythmias, however, there currently is no imaging to visualize and understand their mechanisms in arrhythmogenesis. The overall objective of this proposed project is to use a 3D panoramic imaging system to visualize these processes in transgenic murine hearts with atrial and ventricular arrhythmias to develop new treatment strategies for humans with arrhythmias.